Mechanisms of Synaptic Specificity in Visual Circuits

ABSTRACT
Efficient sensory processing requires the development of precisely wired circuits. Sensory deficits are common
in neurodevelopmental disorders (NDDs), such as fragile X syndrome (FXS), underscoring the importance of
proper wiring. Despite this, the mechanisms underlying precise sensory circuit wiring and the etiology of sensory
dysfunction in NDDs remain poorly understood, precluding development of effective therapies. To address these
gaps in knowledge, we have utilized the visual circuitry of the mouse superior colliculus (SC) to elucidate
fundamental mechanisms of circuit wiring and uncovered novel sub-circuit-specific visual deficits in FXS mice
(Fmr1-/y). Specifically, we will focus on the mechanisms by which topographic maps of space encoded by retinal
ganglion cells (RGCs) in the eye and Layer 5 neurons in primary visual cortex (L5V1) are formed in the SC.
Previous studies by us and others suggest that each stage of visual circuit development in the SC - RGC
mapping, visual map alignment, and circuit consolidation - is dependent on neuronal activity; however, the
mechanisms underlying each are poorly understood. Based on our previous and preliminary data, we propose
a model in which the activity-dependent mechanisms underlying each stage of visual circuit development in the
SC are distinct. We will test this model in three specific aims, leveraging a unique combination of cutting-edge
techniques and novel genetic mouse models. In Aim 1, we will test previously developed computational models
of L5V1 alignment by manipulating neuronal activity in the SC (Aim 1A) or retina (Aim 1B) and evaluating
changes in topographic organization and visual function in the SC. In Aim 2, we will determine when and where
Fmr1 is required during visual circuit development in the SC. Specifically, we will elucidate the stage-specific
roles of Fmr1 in the development and maintenance of visual map alignment (Aim 2A) and maturation of visual
function in the SC (Aim 2B), as well as the region-specific roles in each (Aim 2C). In Aim 3, we will build on our
exciting preliminary data, suggesting that visual experience and Fmr1 may interact to regulate the maintenance
and/or maturation of visual circuits in the SC. To test this possibility, we will determine the requirement of visual
experience for visual circuit organization and function in control (Aim 3A) and Fmr1-/y (Aim 3B) mice. These
studies will be complemented with those exposing mice to a visually-enriched environment to test the possibility
that it may rescue deficits observed in Fmr1-/y mice (Aim 3C). These studies will uncover fundamental
mechanisms of sensory circuit formation and establish a platform for elucidating the molecular underpinnings of
activity-dependent wiring. Further, we will gain critical insight into the etiology of sensory dysfunction in FXS, the
treatment of which could have reverberating positive impacts on deficits in social communication, anxiety, and
intellectual development.

Public health relevance
PROJECT NARRATIVE Efficient sensory processing relies on the development of precise connectivity and deficits in sensory processing are common in many neurodevelopmental disorders (NDDs). However, the mechanisms underlying circuit development and the etiology of sensory deficits in NDDs are poorly understood, precluding the development of effective therapies. In this proposal, we will use a combination of in vivo anatomic, electrophysiologic, and environmental modification techniques in transgenic and knockout mouse models to elucidate the mechanisms by which proper connectivity is established in the developing visual system and how these processes are disrupted in NDDs.